T32 Predoctoral Training Grant in Genetics

This is an application for T32 funding to support predoctoral training in genetics at the University of Georgia.
The award will replace the current T32 program, which has successfully trained students for 45 years. The
Genetics Training Program (GTP) seeks to (i) help a diverse cohort of students develop the research and
professional skills to become leaders in the biomedical workforce, and (ii) to create a supportive training
environment where all students have the potential to succeed. To this end, our program of study provides
graduate training across a broad range of modern genetics subdisciplines, coupled with professional
development and career awareness. Foundational to our training goals, our program strives to maintain a
training environment that is welcoming and inclusive, and to prioritize the holistic development of both trainees
and their mentors. The 51 trainers come from 10 departments and span the breadth of genetics research.
Trainers are committed to mentoring and to providing a supportive and inclusive training environment, and the
program has mechanisms in place to support trainers as they continue to develop their own mentoring skills.
GTP students enter UGA through one of two umbrella programs that employ a holistic admissions process.
During the first semester, coursework and laboratory rotations within these programs help students develop the
skills needed for success in graduate school. Students who choose GTP trainers for thesis research then
become part of the GTP community and are eligible to apply for traineeships. We request funding for 10
traineeships per year. Traineeships are awarded during a student’s second and/or third year of graduate
school, with a duration of one year and the possibility of renewal. The GTP core curriculum is required for
trainees and is open to all students in GTP trainer laboratories. This curriculum includes training in genetic
methods and analyses, quantitative and analytical skills, and oral and written communication. Courses
emphasize cohort-building and use active learning strategies, and skills are mastered through iterative
practice. The importance of rigor and transparency, and of responsible conduct in research, are introduced in
specialized foundational classes and then reinforced through integration into subsequent coursework and
thesis research. Professional development opportunities expose students to the diverse career options
available to them and help students gain the skills and networking opportunities needed to access these
positions. Student progress is monitored through regular assessment, and students are guided toward
increasing research independence through active mentoring. Students graduate with advanced genetics
knowledge, strong analytical and communication skills, and the confidence to lead and succeed in the
biomedical workforce. We will track student outcomes and use program assessments to advance evidence-
based innovations in mentoring, training, and diversity efforts within our program. We will also share our
successes to catalyze positive changes in graduate education across the life sciences at UGA.

Public health relevance
The Genetics Training Program provides directed training and support of a diverse cohort of pre-doctoral students who are conducting genetics research at the University of Georgia. The training program, which funds ten T32 traineeships per year, emphasizes rigorous, ethical, and inclusive training of the next generation of scientists. Students receive training in modern genetics, quantitative methods, communication, and other professional skills that will enable them to become leaders in the biomedical workforce and excel in careers in research, teaching, biotechnology, and government.